Maternal stress and undernutrition: Interactive effects on newborn and child outcomes in Ethiopia”

PROJECT SUMMARY/ABSTRACT
Maternal prenatal stress and nutrition influences fetal growth and long-term child outcomes. Maternal psychological stress
and undernutrition frequently co-occur and affect overlapping biological stress axes involved in fetal growth and
neuroendocrine development. Still, little is known about the interactive effects of maternal prenatal stress and nutrition on
fetal and long-term child outcomes. The proposed K99/R00 research will leverage data from the ongoing “Enhancing
Nutrition and Antenatal Infection Treatment for Maternal and Child Health” (ENAT) trial in rural Ethiopia to examine
interactive effects of maternal prenatal stress and nutrition intervention on fetal and child outcomes. ENAT randomized
2390 pregnant women to receive an “enhanced nutrition” package or “standard care” and collected data on maternal
prenatal stress (Cohen's Perceived Stress Scale) throughout pregnancy. Existing ENAT data will be used to determine
independent and interactive effects of maternal prenatal stress and nutrition intervention on birthweight-for-age (Aim 1,
K99). During the R00 I will conduct a new follow up study with ENAT mother-child dyads at 36 months postpartum to
assess children's stress-sensitive outcomes (Aim 2, R00). Specifically, the developmental follow-up study will assess
child outcomes related to attention, stress reactivity, memory, and socio-emotional functioning. I will also use
biospecimens from ENAT to examine whether maternal and newborn telomere lengths can serve as biomarkers of in-
utero programming of BWAZ and child outcomes in relation to maternal prenatal stress and nutrition (Aim 3, R00). I
hypothesize that maternal prenatal stress and nutrition intervention will have main and interactive effects on newborn and
childhood outcomes. I also hypothesize that maternal and newborn telomere length will serve as biomarkers for prenatal
programing effects of maternal stress and nutrition. My long-term career goal is to lead independent multi-disciplinary
research delineating the complex ways in which biological and psychosocial factors influence fetal and child development
in low resource environments. This award would allow me to acquire basic science knowledge of maternal-fetal nutrition
and telomere biology, technical skills in advanced neurodevelopmental assessments including eye-tracking and
electrocardiography, and practical skills in primary data collection and research management in a low-income country.
During the R00 I will independently lead an innovative child development research study in rural Ethiopia. The proposed
research aligns with NICHD's goal to improve pregnancy outcomes to maximize the lifelong health of women and
children and to help all children thrive. The proposed study will generate epidemiologic and biologic evidence linking
maternal prenatal nutrition and stress with newborn and childhood outcomes that are sensitive to prenatal stress and
predict long-term outcomes related to school achievement and mental health. I intend to use this knowledge to guide
public health decisions regarding pre- and postnatal intervention for the millions of women living in poverty both
domestically and globally and to develop future intervention to support child development in low resource settings.

Public health relevance
PROJECT NARRATIVE The proposed K99/R00 study will use a clinical nutrition intervention trial in rural Ethiopia to determine interactive effects of maternal prenatal stress and nutrition intervention on newborn weight-for-age and stress-sensitive child outcomes related to visual attention, memory, stress reactivity, and socio-emotional functioning at 36 months postpartum. We will also examine whether maternal and newborn telomere length serves as biomarkers of the biologic mechanism underling hypothesized associations. Insight from this project will cast light on the importance of antenatal intervention to reduce commonly co-occurring maternal prenatal stress and undernutrition among millions of women residing in low- resource settings.